Neuro-inflammation in Postoperative Cognitive Dysfunction: CSF and fMRI Studies

This is a K76 Beeson career development award for Dr. Miles Berger, a geriatric neuro- anesthesiologist
with a focus on postoperative cognitive disorders. Each year >16 million older Americans undergo
anesthesia and surgery, and up to 40% of these patients develop postoperative cognitive dysfunction
(POCD), a syndrome of postoperative thinking and memory deficits. Although distinct from delirium, POCD
(like delirium) is associated with decreased quality of life, long term cognitive decline, early retirement,
increased mortality, and a possible increased risk for developing dementia such as Alzheimer’s disease.
We need strategies to prevent POCD, but first, we need to understand what causes it. A dominant theory
holds that brain inflammation causes POCD, but little work has directly tested this theory in humans.
Our preliminary data strongly suggest that there is significant postoperative neuro-inflammation in older
adults who develop POCD. In this K76 award, we will prospectively obtain pre- and post-operative
cognitive testing, fMRI imaging and CSF samples in 200 surgical patients over age 65. This will allow us to
evaluate the role of specific neuro-inflammatory processes in POCD, its underlying brain connectivity
changes, and postoperative changes in cerebrospinal fluid (CSF) Alzheimer’s disease (AD) biomarkers,
such as the microtubule-associated protein tau. This project will advance understanding of neuro-
inflammatory processes in POCD and clarify the potential link(s) between these processes and
postoperative changes in AD pathology, in line with the National Institute of Aging’s mission to understand
aging and fight cognitive decline due to AD. During this K76 grant period, Dr. Berger will also complete an
individually tailored MS degree in Translational Research that will include training in immunology methods,
fMRI imaging, cognitive neuroscience, geroscience, and physician leadership. This career development
plan will give Dr. Berger the transdisciplinary skills to pursue his longer term goal of improving postoperative
cognitive function for the more than 16 million older Americans who have anesthesia and surgery each
year.

Public health relevance
Project Narrative More than 16 million older Americans undergo anesthesia and surgery each year. Up to 40% of these patients develop postoperative cognitive dysfunction (POCCD), a syndrome of thinking and memory deficits that last for weeks to months after surgery, and which is associated with long term cognitive decline and a possible increased risk of developing Alzheimer’s disease. In this project, we seek to better understand inflammation within the central nervous system (i.e. brain and spinal cord) after surgery, and to discover whether it is associated with POCD.